Omics in Urologic Research-New Frontiers Driving Precision Medicine

DESCRIPTION (provided by applicant): This R13 proposal seeks funds to provide 25 travel awards of $500 each to the most promising trainee investigators (Graduate Students, Residents, Clinician-Scientist / Post-Doctoral Trainees and faculty below the rank of Assistant Professor) and to increase representation by Underserved Minorities of this status to attend and participate in the 2014 Annual Fall Symposium of the Society for Basic Urological Research (SBUR) to be held November 13th -16th in Dallas, TX. The SBUR is a society of scientists and physician- scientists specializing in research on the normal and pathological conditions of tissues of the human genitourinary (GU) tract. GU developmental anomalies and diseases afflict males and females, young and old, and cost the US approximately $11 Billion a year in health costs. The overall objective of the annual Symposium is to share new findings at a multidisciplinary level, to promote interaction among members and other interested scientists, to inspire and promote the success of trainee scientists, and to highlight new areas of research and funding opportunities. This year, the theme of the Symposium is Omics in Urologic Research: New Frontiers Driving Precision Medicine. The specific goals of this Symposium are: 1) to inspire young and established investigators to utilize current knowledge in the field to advance the frontiers of basic and translational urologic research; 2) to promote and advance the careers of new investigators in the field of urologic research; 3) to provide a forum for networking, interaction, and establishing new collaborations between investigators focused in GU development and disease those from other disciplines, and 4) to celebrate the excellence, depth, and diversity of basic urologic research pursued by the members of the organization. Research topics that will be covered during the Symposium include: Omics: Drivers from bench to bedside; Emerging transcriptomics and novel pathways; Models and disparity in urologic diseases; Molecular markers and targets for urologic diseases; and emerging treatment strategies for advanced urologic cancer. All invited speakers are leaders in their respective fields, offering extensive knowledge and experience to the audience. Selection of travel awardees will proceed through a defined process whereby applicants are ranked by the Abstract Review Sub-Committee, which works with the Executive Council of the SBUR to issue individual awards to promising and exceptional Trainee applicants. The Executive Council ensures effective representation of both genders in the awardees and, through a specific campaign, seeks applicants of Underrepresented Minority populations. If funded, this project will contribute to the educational objectives of the meeting by enhancing participation of bright and promising Junior Investigators, Physician-Scientist and Postdoctoral Trainees and Students and increase participation in research by members of underserved minority Trainees.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Society for Basic Urological Research (SBUR) hosts an annual Symposium that seeks to advance basic and translational scientific research focused on human genitourinary (GU) development and disease. This year's topic is: "Omics in Urologic Research: New Frontiers Driving Precision Medicine," and the goals of the Symposium are to present cutting-edge research by leading investigators and promising trainees focused on Omics including genomics, proteomics, transcriptomics, and metabolomics that have emerged as important techniques relating to large-scale analyses to understand disease progression, biomarkers for diagnosis and treatment response, novel targets identification, and therapeutic applications. The project requests funds to provide 25 small travel awards of $500 each to facilitate the travel of exceptional and promising trainees to the Symposium who will be selected based on a review of scientific priority and impact based upon a submitted abstract and consideration of career goals. A subset of these awards will be targeted to minority applicants to increase participation. This project will facilitate the ability of promising young investigators t pursue high- impact, innovative research that will improve understanding the pathobiology, and improving the diagnosis and treatment, of GU developmental anomalies and disease.